STUDIES WITH A TRANSPLANTABLE ISLET CELL TUMOR

Insulin dependent diabetes mellitus appears to be a heterogeneous group of disorders resulting from numerous distinct etiologies. However, insulin deficiency secondary to overt B cell failure appears to be the key pathogenic event and the severity of diabetes may be relatd to the ability of the B cell to diabetes, predisposes a need to delineate the factors which regulate its growth and affect its sensitivity to injury. Motivated by this need, studies are proposed which suggest that a transplantable insulin producing tumor may provide a useful experimental model to test hypotheses concerning these issues. Support is requested for immunehistochemical, electron microsopic, radio-autographic and morphometric studies which will characterize the effects of hyperinsulinemia and hypoglycemia on islets of adult tumor recipients. Studies are proposed which will evaluate the permissive role of pituitary, adrenal and vagus nerve factors on B cell replication and responsiveness to glucose. In addition, investigations proposing to determine if the functional activity of the B cell mediate its susceptibility to injury are described. Results obtained from these studies will provide useful information concerning the potential In Vivo extrapancreatic requirements of replicating B cells and may implicate mechanisms which protect the B cell from acute injury.